CORE--TECHNOLOGY AND INFORMATION SERVICES

The Technology Core Service includes the following support activities: 1. Programming 2. General technical support 3. Server administration 4. Server upgrades 5. Database creation and management 6. Training The Informatics Core Service includes the following support activities: 1. Development of statistical and other quantitative methodologies 2. Methods applications and consultation 3. Continuing education 4. Designing, writing, and supporting original software for data collection and analysis 5. Original contributions to the statistical and methodological literature The Graphic Core Service includes the following support activities: 1. Scientific illustration, poster and presentation design 2. Photographic services 3. Video services